HIV Complex Causal Modeling: Gut Microbiome, Drug Use, and Immune Responses

PROJECT SUMMARY/ABSTRACT
Human immunodeficiency virus (HIV) acquisition often co-occurs with drug use disorders (DUD),
particularly in the context of injected drug use. Individuals with DUD or those living with HIV/AIDS have been
found to commonly experience changes in the balance of gut microbiota (GM) in their gastrointestinal tract.
The gut, which is considered the body's largest immune organ, harbors trillions of microorganisms that
influence how our body responds to neurological and immune challenges or inflammation. Thus, DUD, HIV,
GM, and immune responses form a complex interplay, influencing each other.
To elucidate the causal relationship of HIV acquisition, we will leverage genome-wide association studies
(GWAS) summary statistics and existing datasets. Our primary analytical strategy involves employing
Mendelian randomization (MR) combined with mediation analysis. Utilizing MR analysis, which relies on
GWAS summary statistics, we will deploy static GWAS-identified genetic markers as instrumental variables to
address confounding factors while inferring causal effects. We will examine four distinct DUDs, including use
disorders of cannabis, cocaine, tobacco, and opioids. Our investigation will analyze a large-scale human GM
GWAS, GWAS of target immune-related biomarkers, and our ongoing HIV GWAS. Within the MR framework,
our outcome trait is HIV acquisition, and DUDs are exposure variables. Through univariate MR and multivariate
MR, we aim to identify drug-specific causal effects on HIV risk and immune responses. We will also investigate
genetic correlations among these traits. Furthermore, we will infer the causal mediation relationship among
DUD, GM, and immune responses in HIV risk, providing insights through the assessment of causality and
mediation effects. In summary, finding causal effects between DUD and HIV acquisition is essential for
designing effective prevention and intervention strategies, guiding public health policies, understanding the
mechanisms involved, and ultimately reducing the burden of HIV in populations affected by drug use.

Public health relevance
NARRATIVE “Ending the HIV Epidemic in the US” is an ambitious initiative launched in 2019, aiming to eradicate HIV by 2030 in the United States. To achieve this, a critical need is to identify the root causes contributing to HIV acquisition. Finding causal effects between drug use disorders and HIV acquisition and how these causal effects are mediated by the hosts’ gut microbiota and immune responses are essential for designing effective prevention and intervention strategies, guiding public health policies, understanding the mechanisms involved, and ultimately reducing the burden of HIV in populations affected by drug use.